Center for therapeutic targeting of the Fusion Oncoprotein of Fibrolamellar Hepatocellular Carcinoma

Project Summary / Abstract
Fibrolamellar hepatocellular carcinoma (FLC) is a usually lethal primary tumor in children, adolescents and
young adults. The primary tumor is initiated and driven by a single alteration in the DNA: A deletion of ~400kb
that results in a fusion gene between the heat shock co-chaperone DNAJB1 and the catalytic subunit of protein
kinase A, PRKACA. If the tumor is limited to the liver, then surgery is the accepted therapy. However, if the
tumor has metastasized, there is no accepted therapy. This project will determine how the fusion oncoprotein
leads to pathogenesis and will develop therapeutics targeted to the fusion oncoprotein. The first two projects
will explore the pathogenesis: In project 1, what is different about the fusion oncoprotein that causes changes
in the cell; In Project 2, how its expression in human organoids or in mouse tissue leads to a specific pathology
in the liver. The next two projects will explore the therapeutics: In project 3 targeting to the fusion mRNA
transcript with shRNA and anti-sense oligonucleotides and in Project 4, targeting the fusion oncoprotein
through small molecules to block activity, or small molecules to send it to the proteasome, or small molecules
for allosteric inhibition.
Page 98
Project Summary/Abstract

Public health relevance
Project Narrative: Our ability to understand human cancers has been revolutionized the past two decades by the sequencing of the human genome and the discovery of specific genes that encode proteins that drive cancers. Many of these, especially in children, are fusions of two different proteins. This project focuses on one specific lethal liver cancer that is driven by such a fusion oncoprotein and studies how that oncoprotein produces the cancer and how to block it and eliminate the tumor. Page 99 Project Narrative